Improving Opioid Use Disorder Treatment for Hospitalized Patients with Endocarditis

PROJECT SUMMARY/ABSTRACT
Patients hospitalized for opioid use disorder-associated infective endocarditis (OUD-IE) have distinctly poor
outcomes and high costs. Despite the availably of effective treatment for opioid use disorder and the opportunity
to intervene during hospitalization, health care staff tend not to address opioid use disorder during hospitalization
for OUD-IE. Existing models of hospital care for patients with opioid use disorder can inform hospital care delivery
for OUD-IE patients, though significant adaptation of these models is needed to meet the unique needs of OUD-
IE patients related to their prolonged hospital stays. Little is known regarding how to best deploy evidence-based
opioid use disorder interventions for medically hospitalized patients. The aims of the proposed study are to: 1)
Characterize current practices of health care staff regarding hospital care delivery for OUD-IE patients; 2)
Examine the appropriateness, feasibility, and acceptability of implementing evidence-based opioid use disorder
care for hospitalized OUD-IE patients; and 3) Adapt an intervention for hospitalized OUD-IE patients and develop
a corresponding toolkit of implementation strategies. To accomplish these aims, I will engage health care staff
who care for OUD-IE patients at the Hospital of the University of Pennsylvania and will rely on mentorship and
collaborators from faculty in the University of Pennsylvania's Schools of Nursing and Medicine. Qualitative data,
in conjunction with expert opinion, will be integrated to inform an adapted opioid use disorder intervention for
OUD-IE patients and a corresponding toolkit of implementation strategies. Findings from this study will increase
the currently limited efficacy of care delivery for hospitalized patients with opioid use disorder and ultimately
enhance their outcomes. This program of research and corresponding training activities will facilitate the
applicant's long-term goal of pursuing an academic research career committed to improving the quality of care
and outcomes for hospitalized people with substance use disorders through implementation science. Specific
training goals are to: 1) Understand current practices for care delivery for hospitalized patients with OUD; 2)
Acquire a strong foundation in methods for the proposed project and for future research; 3) Develop skills related
to designing and implementing new practices in hospitals; and 4) Integrate professional development, grant
writing, and scholarship to prepare to be an independent researcher.

Public health relevance
PROJECT NARRATIVE The proposed study would be the first to examine potential mechanisms to improve opioid use disorder (OUD) treatment for hospitalized infective endocarditis patients, a population with particularity lengthy hospital stays and at high risk for morbidity and mortality. This application proposes to adapt an intervention for these patients and develop a corresponding toolkit of implementation strategies in preparation for a hybrid effectiveness- implementation trial. The knowledge gained from this proposal will inform future research on widely implementing interventions for medically hospitalized patients with substance use disorders and evaluating their effects on patient outcomes.